Neuron-SELEX: Development of neuron-specific nanoscale toolkits for single-cell recognition

Project Summary
All neurons are remarkably different and existing approaches do not allow de novo visualization
of specific living cells in intact brains, without laborious tasks of making transgenic animals. The project will
address this grand challenge: our interdisciplinary team will develop and validate novel nanoscopic probes,
to rapidly (<30 min) label specific neurons within highly heterogeneous cell populations. For these
applications, in vitro neuronal selection Neuro-SELEX (systematic evolution of ligands by exponential
enrichment) will be used to generate libraries of nucleic acid-based probes. These aptamer-based tools
will also serve as “pull-out” molecular constructs to identify cell-specific membrane proteins associated with
unique neuronal identity and wiring. As a result, this research will provide a broad spectrum of advanced
nanotools to decipher the organization of neural circuits at the level of single cells and their compartments.
Our preliminary data indicate that the Neuro-SELEX can produce multipurpose toolkits to uniquely
map specific neurons or axons without a priori knowledge about their molecular diversity in the intact
nervous system. These results, together with our published data, provide the scientific premise for three
proof-of-the-concept aims. Arguably, Aplysia is a very powerful experimental model for such technology
development. First, to selectively label identified neurons and glial cells, hybrid fluorescent aptamers will
be generated using chemical evolution for neuron-specific selection. We will develop a high-throughput
cost-efficient system to manufacture molecular probes at a large scale, targeting each key, functionally
identified, neuron within a simple-memory forming circuit. Second, we will design fluorescent probes (e.g.,
modified nucleic acids with fluorophores) for multiplex labeling of several neuronal cell types in vivo. This
bar-coding would allow simultaneous visualization of pre- and postsynaptic partners within the same circuit
in real time. Furthermore, these probes will be chemically modified to self-deliver molecular constructs into
hundreds of target cells without the needs of direct injection, electroporation or making transgenic animals.
Third, in proteomic experiments, we will utilize these probes as specific binding tags or ligands to capture
and identify membrane proteins specific for each neuronal type of the model circuit including possible
synaptic components and receptors.
These versatile nanoprobes, with high selectivity and high-throughput fabrication capabilities, will
be resourceful to test causality relationships between cellular genomes and complex neuronal phenotypes.
Technologies and infrastructure should be applicable to virtually all animal cell types and organs. In
perspective, novel fluorescent markers and molecular reporters can be used in early diagnostics and
therapy for a broad spectrum of neurological and cell-specific disorders as well as in personalized medicine.

Public health relevance
Project Narrative All neurons are remarkably different and existing approaches do not allow visualization of living cells in intact brains without making transgenic animals. Here, the multidisciplinary team will develop and validate novel technology for neuronal selection (Neuro-SELEX) to label specific neurons within highly heterogeneous cell populations and characterize membrane molecules associated with unique neuronal phenotypes. As a result, this research will generate advanced nanoprobes for single-cell deciphering of neural circuits and single-cell biomarker discovery in neuropathologies and diagnostics.